BMT Core - Stanford University

This is a renewal application to RFA-HL-24-010 to propose that the Division of Blood and Marrow Transplantation
and Cellular Therapy (BMT-CT) at Stanford University continue as a Core Clinical Center for the BMT Clinical
Trials Network (BMT CTN). Stanford’s Program will perform ~700 adult transplants/cellular therapies in 2023
including autologous and allogeneic transplants using cells from matched and mismatched related and unrelated
donors, cord blood units, ex vivo manipulated cell products and genetically modified cells, as well as novel
chimeric antigen receptor T cell products. Stanford’s BMT-CT Program participates in basic and clinical research
as a single institution, and within regional, national and international consortia. The Division is supported by a
NIH Program Project Grant with over 32 years of funding of basic scientific research and clinical translational
trials that advance the field. The Program is strengthened by highly experienced biostatics and data management
groups, and a cGMP-compliant, FACT and CLIA certified Cellular Therapy Facility for routine cell processing
and the development of investigational cellular therapies. The Program is a high accrual BMT CTN center and
has enrolled 579 patients to 25 CTN studies. In the past granting period, Stanford investigators served in
leadership roles of both committees and clinical trial protocols. Additionally, Stanford faculty participated on
several protocol development committees and on other steering committees and task forces. Stanford will
continue to leverage the capabilities of its Program to support the research goals of the CTN. It is our collective
mission to advance the field of BMT-CT for patients with rare and difficult to treat blood diseases through high
quality multi-center clinical trials. The goal of the proposed protocol in the current application is to determine
whether a novel strategy can prevent and reduce the risk of developing graft-versus-host disease (GVHD) in
patients lacking HLA matched donors, and thereby improve upon traditional allogeneic BMT. We propose a
phase 1/2 clinical trial to evaluate the safety and efficacy of Orca-T, an engineered donor graft in which a highly
purified Treg product is administered the same day as hematopoietic stem and progenitor cells followed 2 days
later by conventional CD3+ T cells. The target population is patients with ALL, MDS, or AML receiving
myeloablative conditioning followed by HCT using HLA mismatched unrelated donors (MMURDs). This
investigator-initiated study builds upon our prior preclinical and clinical work with the Orca-T graft engineering
platform in the HLA matched donor setting. The primary outcome of the Phase 2 portion is efficacy, as defined
by GVHD-relapse-free survival (GRFS) at one year following HCT. Based on aggregated data, we hypothesize
that the Orca-T allograft in combination with dual-agent GVHD prophylaxis (tacrolimus plus ruxolitinib) will
synergistically and significantly reduce rates of GVHD in adults undergoing myeloablative allogeneic HCT with
MMURDs. The Stanford BMT-CT program is committed to continued participation in BMT CTN trials, contributing
concepts for consideration by the Network, and participating in Network committees and citizenship activities.

Public health relevance
Project Narrative The mission of this grant is to form a network of established blood and marrow transplant centers, such as the Stanford BMT-CT Program, that will collaborate and conduct impactful multicenter clinical trials investigating leukemia, lymphoma, and myeloma, as well as non-malignant diseases such as sickle cell anemia and aplastic anemia. The Division of BMT-CT at Stanford has been an outstanding contributor to past CTN clinical trials with 579 patients enrolled on 25 clinical trials and has been an active participant in CTN committees and related activities. The trial proposed in the current application aims to identify a safe and novel GVHD prevention strategy in patients lacking HLA matched donors, and if successful, will address a main complication that limits safe allogeneic transplantation and is a major source of morbidity and mortality following allogeneic HCT for patients with ALL, AML, or MDS.